Multifunctional Regulation of Prostate Cancer Metabolism by Sigma1 Modulators

Abstract: Prostate cancer (PCa) is a remarkably adaptive disease. First line therapy for PCa is androgen
deprivation. However, resistance invariably emerges, resulting in a lethal phase termed castration-resistant PCa
(CRPC). Even with the profound AR-targeting achieved by current standard of care agents abiraterone and
enzalutamide, CRPC remains incurable. CRPC is characterized by multiple compensatory signaling
mechanisms including reciprocal activation of PI3K/Akt/mTOR signaling and AR-ErbB receptor cross-talk.
Notably, these pathways converge on the signaling networks, feedback loops, and cellular mechanisms that
mediate oncogenic lipid metabolism, which is now recognized as a central driver of CRPC growth and
progression. Meaningful improvement in anti-tumor efficacy is likely to require novel strategies that
simultaneously target the AR axis and the network of compensatory signaling pathways on which CRPC depends.
We have identified Sigma1 as a multi-functional scaffolding protein that is aberrantly expressed in PCa and that
it is required for PCa cell growth proliferation. Sigma1 allosterically modulates cancer-specific associated
proteins involved in driving oncogenic lipid metabolism, including AR and ErbB receptors. Sigma1 also regulates
cellular lipid and protein homeostasis pathways, and plays a critical role in supporting the increased demand for
lipid and protein synthesis associated with tumor growth. We have developed a series of novel small molecule
inhibitors of Sigma1 that disrupt lipid homeostasis and induce targeted degradation of AR and ErbB receptors in
PCa cells, resulting in inhibition of PCa growth in vitro and in vivo with minimal toxicity to normal cells. The
overarching problem addressed in this proposal is how to target the critical mechanisms by which lethal CRPC
becomes resistant to AR-targeted therapy. We hypothesize that Sigma1 serves as a multifunctional nexus
between oncogenic driver proteins and lipid metabolism in PCa, such that Sigma1 inhibition disrupts not only
key drivers of tumor growth and lipid metabolism (AR, ErbB), but also inhibit their downstream and convergent
pathways. In Aim 1 we will define a novel Sigma1-AR-ErbB/PI3K/mTOR-lipid metabolism pathway and feedback
loop that engages ErbB/PI3K signaling in CRPC. We will show that the anti-tumor efficacy of Sigma1 inhibitors
in PCa is due to suppression of this pathway as well as disruption of key convergent and complementary cellular
processes critical for PCa growth fueled by lipid metabolism. In Aim 2 we will demonstrate the efficacy of Sigma1
inhibition in a cohort of patient derived xenograft (PDX) models that encompass the genotypic and phenotypic
heterogeneity of CRPC, using in vitro organoid and in vivo tumor models. Inhibition of Sigma1 in PCa represents
a novel therapeutic approach that targets multiple, interdependent mechanisms involved in CRPC progression and
development of resistance, and it provides a rational basis for designing vertical and horizontal combination
treatment strategies to block the enhanced lipid metabolism that fuels lethal, treatment-refractory CRPC.

Public health relevance
NARRATIVE STATEMENT These studies are relevant to public health because despite considerable progress in our understanding of prostate cancer biology, prostate cancer remains a significant cause of suffering and the second leading cause of cancer death among men and there is a pressing need for new and better approaches to treatment. The remarkably adaptive nature and complexity of prostate cancer progression and the uniform development of resistance underscores the importance of developing a broader range of therapeutic agents and approaches that would increase chances of overcoming the resistance to current therapies. This proposal focuses on elucidating how a novel small molecule therapeutic agent may be used to treat prostate cancer by regulating a novel target and an under-exploited cellular process in cancer cells.